A Multi-Modality, Multi-Scale Approach to Understanding Parturition

Project Summary
The U.S. preterm birth rate is increasing1 and it estimated that if all pregnant women were screened and offered
appropriate available intervention, 95% of PTB would still occur,2 which both indicates that we have exhausted
all currently available options and reﬂects our poor understanding of the molecular mechanisms underlying this
complex and common problem that affects every society in the world. Recent ﬁndings from our labs challenge the
existing paradigm of cervical remodeling in pregnancy. They suggest that perhaps ripening just prior to delivery is
not a simple acceleration or enhancement of the softening that occurs progressively from just after conception
through delivery, but rather is driven by entirely different mechanisms, perhaps by minor ECM components and/or
non-ECM components, some of which are likely still unidentiﬁed. We have come to suspect that the collagen
in the ECM reaches a point after which it rearranges no further, despite continued cervical softening and loss
of strength, and that non-ECM components (e.g. blood vessels) play a signiﬁcant role. These ﬁndings hint at
a compelling alternative paradigm for cervical remodeling, but even more, they reveal a large knowledge gap
in our understanding of parturition in general. Our goal is to address this gap, and explore this potential new
paradigm, by constructing patient-speciﬁc biomechanical models that delineate the structure-function relationship
of the cervix and other tissues that support the fetus (membranes, uterus), based on speciﬁc measurements of
cervical microstructure and maternal anatomy in each individual. We will also explore the contribution of potential
minor extracellular matrix (ECM) and non-ECM informants of cervical remodeling. To this end, we will use our
Rhesus macaque model to longitudinally measure in vivo tissue microstructural properties and maternal anatomy
throughout pregnancy using ultrasound, formulate and validate relationships between ultrasound parameters
and tissue material properties for the cervix in ex vivo gestation-timed samples, explore relationships between
tissue biochemical composition and material properties for the cervix, uterus, and fetal membranes using the ex
vivo samples, and calculate the precise magnitude and regional distribution of tissue stress and stretch for each
macaque using ﬁnite element analysis directly informed by her individual microstructural tissue and anatomical
properties. The fundamental model will be ﬂexible enough to eventually accommodate other potential contributors
to cervical remodeling, such as minor ECM factors, or non-ECM factors. To this end, we will build upon the
successes of our current R01 by expanding our Rhesus model to deeply explore the relationship between cervical
microstructure and maternal anatomy, and search for correlations between biomechanical properties of the cervix
and potential inﬂuences on cervical remodeling of minor ECM, and non-ECM, components. Ultimately, we envision
a modeling tool that incorporates both imaging and biological biomarkers for a comprehensive picture of an
individual's pregnancy, which will allow prediction of birth timing, and could even expose therapeutic targets for
abnormal (preterm or postdates) timing.

Public health relevance
Project Narrative The U.S. preterm birth rate is increasing1 and it estimated that if all pregnant women were screened and offered appropriate available intervention, 95% of PTB would still occur,2 which both indicates that we have exhausted all currently available options and reﬂects our poor understanding of the molecular mechanisms underlying this complex problem that affects every aspect of every society in the world. This proposal addresses our enormous knowledge gap surrounding pregnancy and delivery by taking advantage of the quantitative ultrasound technology we have developed for objective quantiﬁcation of the microstructural changes (collagen organization and cervical softness) in our Rhesus macaque model of pregnancy to construct patient-speciﬁc biomechanical models that are informed by precise imaging biomarkers (measurements of not only an individual's cervical microstructure, but also her cervical and uterine anatomy). This personalized modeling tool will be designed to easily accommodate additional relevant biomarkers (e.g. from blood or cervical secretions) as future research develops.